Administrative Core

PROJECT SUMMARY / ABSTRACT – ADMINISTRATIVE CORE
The Administrative Core will provide oversight, support, and administrative management while setting the
overall direction of the Vanderbilt Integrated Center of Excellence in Maternal and Pediatric Precision
Therapeutics (VICE-MPRINT). The goals of VICE-MPRINT are to improve precision therapeutics in maternal
and pediatric populations by addressing key knowledge gaps, to leverage and develop innovative data science
methodologies and tools that support maternal and pediatric precision therapeutics, and to enhance
dissemination and training of maternal and pediatric precision therapeutics. The Administrative Core will
enable the success of the Overall Center through the provision of administrative support and coordination
within VICE-MPRINT, including management of the Support Pool funds. The Administrative Core will also
support sharing of data, protocols, methods, and tools through coordination with the MPRINT KRCC. The
Administrative Core will also oversee the Precision Therapeutics Academy, which will provide a training
environment for predoctoral students, postdoctoral fellows, and junior investigators in maternal and pediatric
precision therapeutics research. Drs. Kannankeril and Van Driest, Co-principal Investigators for VICE-MPRINT,
will serve as Director and Associate Director of the Administrative Core. They will be supported by a full-time
Program Manager as well as experienced administrative officials and grants management staff. To facilitate
the success of the Administrative Core, and the VICE-MPRINT Center, an Internal Scientific Advisory Board
and External Advisory Board will advise the Directors, in addition to regular input from the MPRINT Steering
Committee and NICHD External Program Consultants.